New Down syndrome brain organization revealed by single-cell genomics

PROJECT SUMMARY/ABSTRACT
Nearly 100% of Down syndrome (DS; trisomy of human chromosome 21) individuals that live into their 5th decade
of life and beyond, show Alzheimer’s disease (AD)-like dementia and neuropathology (DS-AD), representing a
prominent DS comorbidity that has recently been reported as the leading cause of death for DS adults. Beyond
trisomy of chromosome 21, which includes the key AD gene, amyloid precursor protein (APP), the molecular
mechanisms underlying DS-AD have resisted identification. There are no disease-modifying therapies (DMTs)
to prevent or treat DS-AD, which could improve DS quality of life and lifespan.
This INCLUDE proposal will transform our understanding of DS by revealing the transcriptomic (RNA) and
genomic (DNA) single-cell landscape of the aging DS individual, and especially the DS-AD brain, by centering
upon a novel human brain molecular mechanism that might underlie DS-AD: somatic gene recombination (SGR)
and resultant genomic and transcriptomic heterogeneity. SGR has the potential to change the DNA blueprint of
DS brain cells resulting in functional consequences for brain cells that could explain DS-AD onset as well as
other DS brain comorbidities such as autism and epilepsy. SGR has not been examined in DS brains, which if
operational, would provide a fundamentally new view on how genes and gene dosage act to promote DS-AD
over time. SGR is known to act on APP in normal and sporadic AD neurons, resulting in thousands of new APP
variants within individual human brains and has been independently confirmed in the scientific literature. The
proven increases in DS brain gene expression, combined with the identified linkage of gene expression to SGR,
implicates genes transcriptionally increased by trisomy 21 as new targets for SGR in DS-AD. APP is likely the
“tip of the iceberg” for DS-affected genes in neurons and non-neuronal cells, with implications for both DS as
well as other states of the normal and diseased human brain. Three independent, but deeply-connected,
Research Elements (REs) will be completed by a proven, collaborative team of molecular biologists,
neuroscientists, neurologists, bioengineers, and bioinformaticians to test the hypothesis that SGR contributes
to DS brain deficits and DS-AD by altering known and unknown disease genes at the single-cell
transcriptomic and genomic level within the DS brain. RE1 and RE2 will use cutting-edge sequencing
technologies to interrogate the transcriptomic and genomic heterogeneity of single nuclei from DS and DS-AD
brains compared to controls, and will informatically integrate transcriptomic expression, chromatin accessibility,
novel isoform detection and genomic mosaicism forms, including gencDNAs, within single cells across cell types
and with age. RE3 will explore the functional consequences SGR in primary neuronal and induced pluripotent
stem cell (iPSC) models towards understanding the functional implications of disease enhanced SGR, and the
therapeutic opportunities that SGR unveils.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease-like neuropathology is a prominent comorbidity in Down syndrome (trisomy of chromosome 21) individuals and remains incompletely understood and without therapeutic options. This proposal could transform the Down syndrome field and identify new therapeutics by elucidating the roles of somatic gene recombination in the Down syndrome brain through the use of cutting-edge molecular biological approaches to define transcriptomic and genomic alterations within human brain single-cells. The derived data could transform our understanding of the etiology and progression of Down syndrome brain disorders while offering the first efficacious therapies to delay or possibly prevent Down syndrome Alzheimer’s disease based upon targeting the enzymology of gene recombination, particularly reverse transcriptases, in the human DS brain.